An oral vaccine against Chlamydia trachomatis

Abstract
This proposal is to produce IND-enabling data for supporting clinical trials of an attenuated clone
of the mouse-adapted Chlamydia muridarum (CM) as a novel oral vaccine known as intrOv for
protecting humans from sexually transmitted infection with Chlamydia trachomatis (CT).
Extensive searching for a subunit vaccine against CT has not produced a licensed vaccine. One
of the challenges is that all 8 STI-causing CT serovars (D to K) are significant human pathogens
globally. We are proposing to develop intrOv into an oral vaccine against 8 CT serovars. Following
a single oral inoculation, CM can establish long-lasting colonization in the mouse gastrointestinal
(GI) tract but without causing any significant pathologies; Oral CM induces Th1-dominant
transmucosal immunity against subsequent infection in the genital tract and airway but without
altering CM colonization in the GI tract; CM colonization in the GI tract for 1 week is sufficient for
inducing protective immunity in the genital tract and antibiotics clearance of GI tract CM does not
compromise the genital protective immunity; To improve the safety of CM as an oral vaccine,
genital tract pathogenicity-attenuated CM clones have been generated by various labs but the
clone designated as intracellular Oral vaccine vector or intrOv is particularly attractive since it is
still able to induce transmucosal protection in the genital tract but no longer maintains long-lasting
colonization in the colon; IntrOv induces IFN+ILC3s and is also inhibited by IFN+ILC3s; Finally
intrOv-induced transmucosal immunity conferred cross-species protection against CT in the
genital tract, validating previously observed CM induction of anti-CT immunity. Thus, we
hypothesize that oral intrOv protects human genital tract from CT infection and the intrOv-induced
IFN+ILC3s in the gut may present cross-species epitopes to lymphocytes for mediating Th1-
dorminant transmucosal immunity. We will test these hypotheses by validating the protection
efficacy of intrOv against genital CT in mice and large animals, identifying protective correlates
and CT antigens for improving clinical assays & intrOv efficacy and improving the quality and
safety of intrOv as a human oral vaccine. Our hypotheses are consistent with these successful
examples of using animal-adapted microbes to protect against human pathogens: cowpox as a
vaccine against smallpox, BCG (M. bovis) against M. tuberculosis and meningococcal vaccine
against gonorrhoea.

Public health relevance
Narrative The proposed experiments will both provide IND-enabling data to support clinical evaluation of intrOv as a novel oral vaccine against CT infection in the human genital tract and reveal new mechanisms of transmucosal immunity induced by an oral vaccine.